Cell type-specific epigenetic control of brain function

Summary: There are no effective treatments for the majority of brain disorders. Even diseases like epilepsy, for
which many powerful therapies exist, are intractable in about one third of affected individuals. One of the reasons
that make treating brain disorders like epilepsy so difficult is the complexity of the underlying pathology that is
tough to correct with single-target approaches and poorly understood. Recent preclinical studies have begun to
address this challenge by exploring aberrant microRNA-induced silencing as a pathological mechanism
contributing to epilepsy. MicroRNA-induced silencing is a powerful epigenetic mechanism that controls neuronal
function and is dysregulated in epilepsy. MicroRNAs repress translation or initiate the degradation of hundreds
of target mRNAs and can regulate several components of the same biological pathway. This makes them
powerful regulators of biological processes but also imposes a substantial challenge to maintain functional
specificity. MicroRNA specificity in the brain is most likely achieved through different molecular environments in
specific cell types and brain circuits; yet, not much is known about these factors which prevents the field from
fully understanding their biology as well as their potential and risks as drug targets. The proposed research will
address this challenge by using novel adeno-associated virus (AAV)-assisted strategies to reveal the cell types
and cell type-specific target mRNAs that mediate microRNAs’ control of brain function in the context of epilepsy.
Based on preliminary data suggesting that effects of a specific microRNA on seizure control and neuronal
morphology are mediated through different cell types, the proposed research will test the central hypothesis that
microRNA specificity is achieved through cell type- and brain circuit-specific control of microRNA function, so
that for select proconvulsant microRNAs, the effects on seizures and healthy brain function can be separated by
cell type and mRNA targets. To test this hypothesis, a two-pronged approach will be followed to (1) assess cell
type-specific control of brain function of key microRNAs critical in epilepsy, and (2) identify their cell type-specific
target mRNAs to reveal the molecular pathways contributing to their diverse functions. Leveraging the synergistic
expertise of a multidisciplinary team in microRNA biology, epilepsy, cognition, and gene network analysis, two
aims are proposed. In aim 1, microRNAs will be inhibited either pan-neuronally, in excitatory neurons, in inhibitory
neurons, or in astrocytes to identify the cell types that mediate control of seizure susceptibility and recurrent
seizures in epilepsy, neuronal dendritic spine morphology, and cognition. In aim 2, cell type-specific inhibition of
microRNAs combined with isolation of mRNAs silenced or actively translated only from cells in which the
microRNA is inhibited, will be used to experimentally identify the cell type-specific mRNA targets of, and thus
biological networks regulated by, the same microRNAs as tested in aim 1. This research will provide essential
insight into fundamental function of microRNAs in the brain and will be a critical step towards fully understanding
the potential of microRNAs as treatment targets in epilepsy and other brain disorders.

Public health relevance
NARRATIVE Brain disorders like epilepsy have complicated causes that are often difficult to treat by correcting single genes. This research will generate fundamental knowledge about how microRNA-induced silencing, a mechanism that controls many genes at once, functions in the brain and in the context of epilepsy. In the long term, the results may help develop novel therapeutic strategies that target microRNAs to treat epilepsy and other brain disorders, ultimately reducing disease burden and increasing public health.